Regulation of Innate Dendritic Cell CTLA-4

Abstract
Myeloid dendritic cells (DC) are a critical lineage of innate immunity that serve as a principal point of contact and
crosstalk between the innate and adaptive arms of the immune system. CTLA-4 is one of the best characterized
of the immune checkpoint proteins, molecules that serve to balance, regulate, and fine-tune immune activation
with homeostatic inhibition. CTLA-4 is expressed by all major lymphoid lineage effectors; however, its function-
ality has been best characterized in T-cells where it exhibits both cell-extrinsic and cell-intrinsic regulatory func-
tions. Until recently, very little was known about CTLA-4 expression or function in non-lymphoid cell types, par-
ticularly the myeloid lineage dendritic cell subsets. In the original iteration of this renewal application, we provided
preliminary data demonstrating that DC-secreted CTLA-4+ exosomes could bind B7 in paracrine fashion, leading
to vesicle internalization and subsequent downregulation of B7 expression among bystander DC that internalized
the CTLA-4+ exosomes. Conversely, knockdown of DC-expressed CTLA-4 resulted in a dramatic upregulation
of co-cultured CD8+ cell proliferation in vitro as well as enhanced antitumor and antiviral immunity in vivo. These
discoveries and concomitant characterization of myeloid CTLA-4 expression signified a paradigm shift in the
understanding of CTLA-4’s role in immune governance as well as the mechanisms through which innate and
adaptive crosstalk occur. Subsequent data indicated that the expression of DC CTLA-4 is modulated in response
to TH polarizing cues and that regulation in DC appears to be governed in part by the transcription factors GATA3
and C/EBP-b. Further, conditional ablation of CTLA-4 in the C57BL/6 background revealed potential new roles
for DC expressed CTLA-4 in regulatory processes in the thymus and in other lymphoid tissues including Peyer’s
patches. These novel and exciting data have allowed formulation of a refined overarching hypothesis that DC-
secreted CTLA-4+ exosomes act as effector vehicles that shape downstream TH polarization of adaptive re-
sponses as dictated by DC detection of innate signaling cues. By means of three independent aims we will test
this overarching hypothesis by i) defining the role of TH polarizing cues in the governance of DC CTLA-4 expres-
sion and the governance of the CEBP/b and GATA3 transcriptional regulators, ii) defining the mechanisms
through which DC-secreted CTLA-4+ and CTLA-4neg exosomes regulate downstream adaptive TH polarization,
and iii) defining the manner by which DC CTLA-4 expression modulates central tolerance by interrogating the
regulatory T-cell deficits observed in the CD11c-Cre CTLA-4flox/flox C57BL/6 mouse. Completion of these inde-
pendent aims will further elucidate the novel regulatory role of myeloid CTLA-4, furthering the ability to synthesize
effective and powerful vaccination strategies while characterizing critical druggable target interactions and en-
hancing the understanding of complex biological pathways.

Public health relevance
Project Narrative A properly functioning cellular immune response is essential to the eradication of infectious diseases and cancer, whereas inappropriate cellular immune regulation may result in debilitating autoimmune conditions. Given that cellular immunity plays such a critical role in the disease process, a better understanding of the innate regulatory mechanisms governing cellular immunity would allow for the formulation of novel vaccine and pharmaceutical interventions that would enormously benefit human health and well-being. Completion of the work outlined herein will permit the novel regulatory role of myeloid cell CTLA-4 in immune governance to be fully elucidated, enabling enhanced treatment regimens for cancer, viral infections, and autoimmune conditions.